Text and Talk: A multi-level intervention to increase provider HPV vaccine recommendation effectiveness

PROJECT SUMMARY
Multi-level implementation strategies targeting parents and health care providers have potential to
substantially increase the low human papillomavirus (HPV) vaccination rates among the targeted age group of
11- to 12-year-olds. Florida adolescents are particularly vulnerable due to the state’s rank of 4th for HPV-
related cancer diagnoses, but 39th for HPV vaccine initiation and up-to-date rates. The problem addressed by
this proposal is the need for more effective and pragmatic preventive interventions to increase provider HPV
vaccine recommendations. Existing interventions increase HPV vaccine rates only moderately (approximately
5 to 15 percentage points). A multi-leveled focus on provider recommendations and parent receptiveness is
warranted because 90% of unvaccinated teens actually had well visits, provider recommendations increase
HPV vaccination rates 9- to 170-fold, and parents make vaccine decisions. Additionally, national health
agencies endorse two approaches for recommendation: mentioning HPV as one of the needed adolescent
vaccines (bundled) or emphasizing the HPV vaccine benefits (benefits). Yet, the relative effectiveness of
recommendation approaches and effectiveness of approach concordance across provider-parent levels is
unclear. The goal of the proposal is to evaluate the effectiveness of a multi-level (provider and parent)
intervention of two implementation strategies (brief provider training and parent-targeted interactive text
message reminders) on HPV vaccination rates among 11- to 12-year-old boys and girls. Guided by the
Integrated Behavior Model, a meta-theory combining the Theory of Reasoned Action, the Social Cognitive
Theory, and the Theory of Planned Behavior, the central hypotheses are that brief provider trainings will
increase providers’ intentions to recommend the HPV vaccine and the parent-targeted interactive text
messages will increase parents’ salience. Specific Aims are to: (1) To test the overall effectiveness of brief
provider trainings with an embedded comparison of bundled and benefits approaches. (2) To test the overall
effectiveness of interactive text messages for parents with an embedded comparison of bundled and benefits
approaches. (3) Evaluate the effectiveness of the combined brief provider trainings and interactive text
messages for parents with an embedded comparison of concordant and distinct approaches. (4) Evaluate
moderation of the implementation strategies’ effectiveness by clinical practice factors. Hypotheses will be
evaluated with a doubly randomized, two-level nested design for testing two nested implementation factors
(provider training and parent text messaging with bundled or benefits approaches). Thirty clinics will be
recruited from the OneFlorida Clinical Research Consortium. The innovations are the factorial-designed
evaluation estimating the value-added of multi-level implementation and the evaluation of concordant
recommendation approaches across provider- and parent-levels. The significance lies in the potential to lead
the field closer to a sustainable, scalable, and efficacious approach to decreasing HPV-related cancer rates.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it has significant promise to increase human papillomavirus (HPV) vaccination rates among 11- to 12-year-olds, and therefore, prevent cancer. The project is promising for increasing HPV vaccination rates across the US because the straightforward and relatively inexpensive implementation strategies, brief provider trainings and parent-targeted interactive text messages, will easily incorporate into routine primary care. The proposed multi-level factorial-design enables evaluation of the differences between a multi-level (provider and parent) and two single-level implementation strategies, concordant and distinct recommendation approaches across levels, and the influence of clinical practice moderators.